A wearable Device for Continuous Monitoring of Methadone

Opioid overdose is a significant public health problem that has been escalating in recent years. Based on the
statistics from the Centers for Disease Control and Prevention (CDC), the number of overdose-related deaths
surpassed 100,000 from April 2020 to April 2021. This is a significant increase in overdose cases related to
natural and semi-synthetic opioids, synthetic opioids, and psychostimulants. Alarmingly, in the one-year period
leading up to April 2021, fentanyl was the top cause of death for adults between 18 and 45 years old, surpassing
fatalities caused by car accidents, suicide, COVID, and cancer. Methadone is a well-established medication that
has been used for decades to treat opioid use disorder (OUD). However, there is currently no continuous
monitoring device that can provide real-time information on methadone levels in the body. This gap in monitoring
can result in patients not receiving optimal doses of methadone, leading to relapse or overdose. To address this
problem, we propose a wearable device for continuous monitoring of methadone. Our proposed device is a
minimally invasive microneedle technology that can be worn on the skin. This device will continuously monitor
methadone levels in the body, providing real-time feedback to patients and healthcare professionals. The device
is small, discreet, and easy to use, making it ideal for use in various settings. The proposed SBIR project aims
to leverage our innovative microneedle technology to develop a wearable device that can continuously monitor
therapeutic levels of methadone in the interstitial fluid for a week. In order to achieve this, the team will perform
systematic optimization studies on the surface architecture of the sensor to enable highly sensitive, stable, and
selective methadone sensing performance. Aim 1 constitutes in-vitro feasibility studies to find the best chemical
modification strategy with high sensitivity. Aim 2 will involve extending the stability of the sensor to one week of
continuous operation. Aim 3 will assess the selectivity, reproducibility, and shelf life of the developed MN-based
methadone sensors in serum samples and involves further developments in the electronics and the
accompanying app of the device. Upon successful completion of Phase I, Phase II will focus on demonstrating
the utility and establishing reliability of the sensor via extensive clinical studies in both animals and in human
subjects. The device will not only provide accurate and personalized dosing of methadone but also help in
mitigating OUD by alerting patients and healthcare professionals when levels of methadone fall below or rise
above therapeutic levels. This will enable healthcare providers to adjust the methadone dose in real-time,
ensuring that patients receive optimal dosages to prevent relapse and overdose. The proposed wearable device
for continuous monitoring of methadone is a crucial innovation that will help to address the problem of opioid
overdose. The device will provide accurate and personalized dosing of methadone, help to mitigate OUD, and
can be used among different populations. Our proposed device has the potential to improve the quality of life of
patients, reduce healthcare costs, and ultimately save lives.

Public health relevance
Our proposed SBIR wearable device focuses on the continuous monitoring of methadone levels in patients, offering real-time feedback to healthcare professionals. Using minimally invasive microneedle technology, the device provides personalized and accurate methadone dosing, reducing the risk of overdose and mitigating opioid use disorder. The device is designed to advance the field of precision medicine by providing continuous biochemical monitoring of methadone levels, allowing for real-time adjustments to the therapeutic drug dosage based on the patient's individual physiology. Our commitment to excellence and integrity in developing and bringing this innovative technology to market is unwavering, with the potential to significantly improve the lives of those suffering from opioid use disorder.